Discovery of inhibitors against cryptosporidial fatty acyl-CoA synthetase

PROJECT SUMMARY Cryptosporidium (or Crypto for short) can cause life threatening opportunistic infection (OI) in AIDS patients. It is also a category B agent in the biodefense program. Currently, no drug is FDA-approved to treat cryptosporidiosis in AIDS patients, although a single drug nitazoxanide has been approved for use in immune-healthy patients. Our preliminary data have shown that triacsin C, an inhibitor against fatty acyl-CoA synthetase (ACS), could effectively inhibit C. parvum infections in vitro (e.g., IC50 = 136 nM). Most importantly, triacsin C (8-15 mg/kg/d) reduced the production of C. parvum oocysts in an acute infection mouse model by 56% - 88% with no observable toxicity to animals. These observations indicate that essential lipid metabolic enzymes could serve as novel drug targets in the parasite. The long-term goal of this translational research is to explore fatty acid metabolic enzymes as therapeutic targets against cryptosporidiosis. Because fatty acids are essential to all organisms, we hypothesize that ACS and ACC could serve as rational drug targets in Cryptosporidium. To test this hypothesis, we plan to perform experiments to achieve the following two specific aims. In aim 1, we will determine the efficacy of the ACS inhibitor triacsin C (TrC) in a chronic mouse model representing Crypto AIDS-OI. This aim is to extend the study from acute infection model to an AIDS-OI relevant chronic model. The pharmacokinetic (PK) properties of TrC in mice will also be determined for establishing the relationship between the anti-Crypto efficacy and the kinetics of TrC in mouse plasma and in the lumen of the intestine. In aim 2, we will discover new chemotypes with highly improved medicinal chemistry properties by modifying triacsin C (TrC) and by high-throughput screening (HTS) of compound libraries. Using two approaches here, we will increase the chance to obtain a more tractable lead compound, generate alternative leads, and diversify the lead structures. Upon completion of the proposed experiments, we expect to have generated key data, i.e., identified new lead structures with desired efficacy and medicinal chemical properties, for the next phase of ACS inhibitor development for the treatment of Crypto in AIDS patients.

Public health relevance
Project Narrative The protozoan parasite Cryptosporidium causes life-threatening opportunistic infection in AIDS patients (AIDS-OI), and is also listed as a biodefense Category B pathogen. Currently, no FDA-approved drugs are available to treat cryptosporidiosis in AIDS patients, and only a single drug (i.e., nitazoxinade) is approved for use in patients with a healthy immune system. In this drug discovery project, a team of experts in biochemical parasitology and medicinal chemistry will perform experiments to discover new inhibitors against the parasite long chain fatty acyl-CoA synthetase (ACS) for future development of highly selective and efficacious anti-cryptosporidial compounds.